Gravidity-dependent Mechanisms of Myeloid Cell-mediated Protection against Placental Malaria

PROJECT SUMMARY/ABSTRACT
Malaria in pregnancy is one of the leading causes of infant death globally. Placental malaria (PM) is the main
mechanism by which malaria in pregnancy causes birth complications, such as preterm birth, stillbirth, and low
birth weight. During PM, Plasmodium falciparum (Pf)-infected red blood cells sequester to syncytiotrophoblasts
(STB) within the placental intervillous space, stimulating maternal immune cell recruitment and leading to other
placental pathologic changes. With increasing gravidity, the severity of PM decreases and birth outcomes
improve as pregnant women acquire Pf-specific antibodies (Abs) against a variant surface protein – VAR2CSA
– after repeated Pf exposures. Previous work shows that neutralizing Abs against VAR2CSA are important for
protection but do not entirely prevent neonatal complications, which suggests a key role for Ab-mediated effector
functions. Work by our group and others demonstrates that Ab-mediated effector functions are crucial for
naturally acquired immunity to malaria in children. We hypothesize that myeloid cell state, phagocyte localization
at the maternal-fetal interface, and Ab repertoire adapt with repeated Pf exposure in a gravidity-dependent
manner, and that Ab-dependent phagocytosis (ADP) is necessary for limiting PM pathogenesis and improving
neonatal outcomes. To test this hypothesis, we will leverage an extraordinary biobank of plasma and placental
tissue collected from pregnant women enrolled in the DPSP clinical trial (U01 AI1431308). In Aim 1, using novel
spatial proteomic (MIBI-TOF) and transcriptomic (NanoString DSP) imaging approaches, we will determine how
Pf parasitemia and gravidity shape myeloid cell - STB spatial relationships that drive Pf clearance in placental
tissue. We will test whether, with increasing gravidity, inflammatory maternal myeloid cell infiltration will
decrease, and maternal phagocytes will preferentially localize to the Pf-infected STB. In Aim 2, we will utilize in
vitro models to determine how gravidity-induced Ab modifications influence Fc-mediated protection from malaria
in pregnancy. Together, successful completion of these aims will inform vaccine development and therapeutic
strategies to reduce the global burden of malaria in pregnancy.

Public health relevance
PROJECT NARRATIVE Malaria in pregnancy continues to result in significant maternal morbidity and mortality in sub–Saharan Africa, and placental malaria can result in adverse birth outcomes such as preterm birth, stillbirth, and low birth weight. With increasing gravidity, the severity of placental malaria decreases, and birth outcomes improve; but mechanisms driving this gravidity-dependent protection remain unclear. In this proposal, we will evaluate correlates and mechanisms of gravidity-dependent immunity to placental malaria and specifically determine the role of myeloid cell and antibody adaptation in protecting against malaria in pregnancy.